NHGRI Genome Sequencing Program Coordinating Center

Project Summary/Abstract of Funded Parent Award: The proposed NHGRI Genome Sequencing Program Coordinating Center (GSPCC) will provide centralized and collaborative program coordination and scientific leadership to the Centers for Complex Disease Genomics (CCDG) and the Centers for Mendelian Genomics (CMG). The GSPCC will lead an analysis to evaluate when a common disease variant discovery study is effectively complete, develop specifications for a set of common controls for common disease rare variant studies, produce allele frequency data for the CMG program, and provide input into other cross- program activities as needed. The GSPCC will also coordinate logistics, communication, and outreach activities including scheduling and running meetings and teleconferences, hosting websites for data distribution and dissemination of project information to the public, and organizing other efforts as needed by the GSP. Coordination of the program will be done in a spirit of collaboration using creative, flexible, impartial approaches. Throughout the project the GSPCC will work with the funded GSP centers, the steering committee and the NHGRI to help facilitate a comprehensive and successful program of research to meet the goals of the GSP in promoting discovery of disease-related variants and identification of their potential causal roles. Our collaborative CC team is ideally staffed to meet the needs of the GSPCC.

Public health relevance
Project Narrative of Funded Parent Award: The NHGRI Genome Sequencing Program promotes the discovery of disease-related genetic variants and identification of their causal roles. We propose to serve as the Genome Sequencing Program Coordinating Center (GSPCC) by providing scientific leadership for specific cross-program objectives and program coordination for administrative, logistical, and outreach activities. Our team has the expertise and infrastructure in place to facilitate completion of a comprehensive program of research that will meet the goals for the Genome Sequencing Program.